Addressing System-level Barriers to COPD Guideline Concordant Care

Project Summary/Abstract
This supplement aims to support Hewlett Pham for two years prior to medical school matriculation to help him
build a strong foundation grounded in clinical research and achieve his career goals of attending medical
school and becoming an independent researcher. This research fellowship will provide Hewlett with an
opportunity to develop his cognitive skills to implement a care bundle with evidence-based care components,
technical skills to analyze clinical data, interpret results, educate providers and patients; and additional
research skills including implementation science and biostatistics.
Acute Exacerbations of Chronic Obstructive Pulmonary Disease (AECOPD) have led to worse patient health
outcomes and a heavy economic burden on hospital healthcare systems. Overall, the effectiveness of COPD
discharge care bundles has been found to reduce hospital readmission rates; however, other health care
outcomes results such as mortality rates and quality of life have been variable due to a lack of standardized
bundle components and implementation. This emphasizes the need for high-quality studies to identify and
implement the most evidence-based components of a COPD discharge care bundle to improve patient health
outcomes. Hewlett’s research project fulfills this need and will investigate the impact of COPD discharge care
bundles in a large healthcare system setting. Specific Aim 1 of the supplement will identify evidence-based
components for an effective COPD discharge care bundle. Specific Aim 2 will develop a COPD discharge
bundle with frontline providers and patients using PDSA cycles. Specific Aim 3 will pilot the developed COPD
Discharge care bundle on hospital readmissions using an interrupted time series design. This research topic is
within the scope of the parent grant, which focuses on improving the care delivery for individuals with COPD,
specifically, it evaluates the benefit of a pulmonary rehabilitation program on improving COPD health
outcomes. This supplement will have the added benefit of increasing awareness and referral rates to
pulmonary rehabilitation by integrating this guideline recommendation into the COPD discharge care bundle.

Public health relevance
Project Narrative Chronic Obstructive Pulmonary Disease is a noncommunicable disease responsible for being the 3rd leading cause of death globally, highlighting the need for interventions to address this issue. Pulmonary Rehabilitation is one proven intervention that has improved the trajectory of patient health outcomes; however, it is also currently severely underutilized. In this study, we aim to identify and implement evidence-based care components of a COPD discharge care bundle, including referrals to pulmonary rehabilitation for patients in a large hospital healthcare system to improve patient health outcomes and increase utilization rates of pulmonary rehabilitation services.